Intramural Training of NIH Biomedical Imaging and Bioengineering Researchers

Intramural training programs being supported this year include: (1) Imaging Sciences Training Program (ISTP) NIBIB Radiology Fellows in collaboration with the NIH Clinical Center;(2) National Institutes of Health NIBIB/NIST National Research Council Fellows in collaboration with the National Institute of Standards and Technology;and (3) the NIH/NIBIB Bioengineering Summer Internship Program (BESIP) for college students between their junior and senior years in programs leading to a degree in bio- or biomedical engineering. These programs train scientists from the pre-baccalaureate to the post-doctoral levels.